Development and Deployment of Liquid Biopsies in Bench Research and Clinical Trials in the UW Circulating Biomarker Core

Minimally invasive liquid biopsies have revolutionized our understanding of cancer biology and emerged as
biomarkers for disease monitoring and drug development, but have been limited to a few commercial entities or
academic laboratories with the requisite technological capacity. The Circulating Biomarker Core (CBC) at the
University of Wisconsin Carbone Cancer Center (UWCCC) was established in 2017 to leverage innovative
technologies and clinical research infrastructure, to expand access to these biospecimens and assays for UW
faculty and NCI Cancer Centers across the country. Custom UW-developed liquid biopsy technology arises from
a decade-long collaboration between bioengineering and biomarker researchers at UW and offers unparalleled
sensitivity for rare target analytes. Dr. Jennifer Schehr, who played an integral role in developing and refining
custom liquid biopsy technologies since joining the lab of the founding director, Dr. Joshua Lang, in 2015, was
successfully recruited as facility manager for the CBC during its inception and continues to spearhead its
trajectory. The CBC supports NCI-funded research programs both directly through services provided to specific
NCI grants or trials, as well as indirectly as a shared resource facility pursuing the aims of the NCI cancer center
support grant (CCSG) to advance scientific partnerships, precision medicine research and education. Dr. Schehr
delivers high levels of scientific innovation and achievement in biology and biomarker discovery by providing
expert scientific oversight, investment in developing increasingly more powerful computational tools for rapid
data handling, and particular attention to thorough and continuous education and engagement of undergraduate
and entry-level staff. The CBC has now supported 64 different projects involving 34 different protein and nucleic
acid biomarkers, 9 NCI grants and 29 clinical trials from NCI cooperative groups, pharmaceutical companies and
Universities. Dr. Schehr leads the development of new methods for new cancer types, new liquid biopsy
biomarkers, and new clinical applications, as well as the setup, data management and biomarker utility
evaluation for ongoing clinical trials. Dr. Schehr is also actively engaged in developing process controls and
demonstrating analytical validity of custom technologies in pursuit of obtaining regulatory approval for
implementation into routine clinical use. With the recent successful execution of a UH2 analytical validation for
an mRNA panel in prostate cancer circulating tumor cells, the CBC has now gained approval for a UH3
regulatory-approved clinical trial, which will result in the first clinically actionable liquid biopsy developed by the
CBC under Dr. Schehr. Future directions include the development of automated workflows for circulating tumor
DNA (ctDNA) extraction and library preparation from >5,000 plasma samples over the next 5 years for a custom
ctDNA assay that evaluates 821 targeted mutations and high-sensitivity fragmentomic patterning to differentiate
tumor origin. Leveraging innovative problem-solving, computational tools for high efficiency, and an extensive
collaborative network, Dr. Schehr will develop and implement novel liquid biopsy biomarkers into clinical use.

Public health relevance
The Circulating Biomarker Core within the University of Wisconsin – Madison NCI-designated Carbone Cancer Center, led by Facility Manager Dr. Jennifer Schehr, provides centralized liquid biopsy method development, clinical trial sample processing, and assay preparation for regulatory approval for routine clinical use. Dr. Schehr leads the core’s innovative technological problem-solving with her extensive collaborative network leveraging her PhD in immunology, 2 years of FDA-approved assay development, and 9 years of custom liquid biopsy sample processing technology development, supporting 12 active clinical trials, 10 in development and 28 research projects involving 40 investigators, 22 NCI-designated cancer centers, and 10 other institutions. The services of the core aim to accelerate the process from discovery of promising new biomarkers to extensive evaluation for regulatory approval to provide more advanced predictive and pharmacodynamic biomarkers of resistance to clinicians and increase the efficiency of precision medicine approaches for patients with cancer.